Investigating the role of pH in presynaptic homeostatic potentiation at the vertebrate neuromuscular junction

This project continues thirty-two years of research with undergraduate students at Grinnell College, who
participate in all aspects of the research. My laboratory studies synaptic transmission at the vertebrate
neuromuscular junction (NMJ). This project will focus on a phenomenon called presynaptic homeostatic
potentiation (PHP), which refers to the increase in acetylcholine (ACh) release that follows the partial
inhibition of postsynaptic acetylcholine receptors (AChRs). Although the phenomenon is well-known, the
identity or nature of the feedback signal from the muscle to the nerve has eluded researchers for over 40
years. We recently uncovered evidence that protons in the synaptic cleft link the inhibition of AChRs to
the increase in ACh release. Specifically, we found that (i) PHP requires functional acid sensing ion
channels (ASICs), (ii) a decrease in extracellular pH increases quantal ACh release and precludes PHP,
(iii) a strong extracellular pH buffer prevents PHP, (iv) inhibition of the plasma membrane Ca2+ ATPase
(PMCA), which removes protons from the synaptic cleft, increases neurotransmitter release and
precludes PHP, and (v) ASIC channels are present at the mouse NMJ. The projects described in this
proposal will test the hypothesis that protons control PHP at the vertebrate NMJ. Our first goal is to
measure the pH in the synaptic cleft of a mouse NMJ while the synapse is undergoing PHP. We plan to
introduce fluorescent pH indicators into the cleft using AAV viruses. In preliminary experiments we
successfully expressed pHusion-Ex and demonstrated its expected sensitivity to pH. We also plan to
use a ‘kisser” probe that will allow us to examine pH in the immediate vicinity of the PMCA in the muscle
membrane at the synapse. Our second goal is to understand the mechanism by which block of AChRs
lowers the pH in the cleft. Our third goal is to characterize the effect of external pH in the synaptic cleft
by applying acidic buffer via a micropipette and by photolytically uncaging NPE-caged-protons with a UV
laser. Finally, we will explore PHP while allowing muscle action potentials to release internal calcium
from the sarcoplasmic reticulum. PHP has never been investigated under these physiological conditions.
Collectively, these studies will expand our knowledge of pH in the synaptic cleft at the mammalian NMJ,
especially while undergoing PHP. Since protons are increasingly recognized as signaling molecules at a
variety of synapses, what we learn at the NMJ about gain adjustments effected by postsynaptic
detection of neurotransmitter efficacy could represent a simple and widespread mechanism for
maintaining effective communication across synapses throughout the central and peripheral nervous
systems. In addition to its scientific merit, this grant will directly support at least 12 undergraduate
students in consequential research experiences. Most of these students, if not all, will matriculate in a
Ph.D. program in a biomedical science or medical school.

Public health relevance
The vertebrate neuromuscular junction possesses multiple mechanisms for ensuring the fidelity of muscle activation. This proposal seeks to further our understanding of a phenomenon observed at many synapses, called presynaptic homeostatic potentiation. As stated in the goals of the NIH Academic Research Enhancement Award (AREA) R15 program, this research will enhance our understanding of fundamental biomedical process and will support the training of undergraduate researchers.